Vevo 3100 Ultrasound System

Project Summary/Abstract:
The Fujifilm VisualSonics Vevo 3100 is a state of the art preclinical ultrasound imaging system that leverages a
suite of features to improve image quality, acquisition time, and user experience. This instrument will provide
users of the Baylor College of Medicine Mouse Metabolism and Phenotyping Core with an in vivo imaging
platform suitable for mouse and rat models of disease. With this resource, core users will be able to interrogate
the structure and function of the heart and blood vessels in small animals. Additionally, users will be able to
interrogate internal organ and embryo morphology as well as blood perfusion of internal organs. The Vevo
3100’s improvements in image clarity, additional imaging modes such as 4D imaging, and faster acquisition
rates will help users decrease technical variation related to poor image quality. Additionally, the system will
help users to improve the throughput of their data acquisition and reduce biases in scoring of cardiac function
through the use of artificial intelligence and machine learning algorithms to standardize measurements.
Furthermore, advances in acquisition gating and image reconstruction permit the Vevo 3100 to acquire 4D
images providing high temporal and spatial resolution 3D renderings of internal structures such as the heart
and major blood vessels, permitting spatially unbiased assessment of these structures.
The Vevo 3100 represents an exciting and necessary advance in the in vivo imaging capabilities at Baylor
College of Medicine and has the potential to enhance and accelerate our research on the topics of
cardiovascular and congenital disease.

Public health relevance
Project Narrative: Cardiovascular disease and congenital birth defects represent significant burdens to human health and are responsible for approximately 1 in 4 adult deaths, and 1 in 5 infant deaths. State of the art preclinical ultrasound imaging with an instrument such as the Fujifilm Visualsonics Vevo3100 allows for research of causes and potential therapies targeted towards cardiovascular disease and congenital defects.